Leveraging enhanced phenotyping and causal inference approaches to investigate the effect of maternal medication exposures on child outcomes

PROJECT SUMMARY
Nine out of ten women in the US take at least one medication during pregnancy. However, due to ethical and
practical constraints, pregnant women are typically excluded from clinical trials, resulting in a lack of data on
medication safety during pregnancy and potential impact on the child. Epidemiological studies are increasingly
using real-world data (RWD), including electronic medical records (EMRs) to study treatment effects during
pregnancy, but these studies have relied primarily on structured data. This can miss additional context and
information that can be gained from unstructured data sources (i.e. clinical notes), potentially resulting in limited
analytic precision and potential bias. To investigate how maternal medication history affects child health
outcomes, we will use both structured and unstructured data from a large repository of EMRs of mothers and
their children. Specifically, in Aim 1, we will build a registry of mother-child pairs containing high-quality
phenotype data, which we will extract from EMRs using large language models (LLMs). We will use a
paired mother-child data mart that will include all individuals who were pregnant between 2012 and the end of
the study, based on the clinical records at UCM, as well as the clinical records of their children. We will utilize
LLMs to enhance our ability to extract additional medication exposures and phenotypes from clinical notes. In
Aim 2, we will identify robust correlations between maternal medication exposures and early life health
outcomes. We will perform a broad binary statistical association of maternal medication exposures to outcomes
using a medication-wide association study (MedWAS), or modified PheWAS, approach. We will then perform
rules-based refinement of select exposures and outcomes, which will include the application and development
of exposure ascertainment and phenotype algorithms. In Aim 3, we will use causal inference models to
investigate the effects of maternal medication exposures on early life health outcomes. For a subset of
associations identified in Aim 2, as well as associations established in the literature, we will utilize causal
inference machine learning approaches to estimate both binary and continuous (e.g., dose-dependent),
individualized treatment effects. Overall, this work will provide insights into the safety and risks of medication
exposures during pregnancy, which may inform data-driven treatment strategies for pregnant patients. At the
same time, this work will provide me abundant opportunities to grow my computational research skills while
benefitting from the support of diverse collaborators and mentors spanning clinical, informatics, and genomics
expertise.

Public health relevance
PROJECT NARRATIVE To reduce adverse health outcomes during gestation and infancy, we need new ways to evaluate the risks and benefits of drug use in pregnant women. Using paired electronic medical records from mothers and their children, we will apply advanced data mining and causal inference approaches to establish robust correlations between maternal exposures and child health outcomes. This work will contribute to our knowledge of how maternal medication exposures affect child health, which could eventually serve to support clinical decision-making for treatment of pregnant patients.